Identification, characterization, and application of bacterial site-specific vanadium-dependent haloperoxidase enzymes

Project Summary
The incorporation of halogen atoms (F-, Cl-, Br-, I-) in small organic molecules plays a significant role in
modulating their physical properties and biological activities while providing a synthetic handle for additional
chemical modification. The regioselective and enantioselective installation of halogens in a strictly
chemosynthetic manner is technically challenging and frequently utilizes toxic reagents and generates
undesirable byproducts. In contrast, Nature has developed efficient enzymatic strategies to incorporate aqueous
halide ions into organic scaffolds with negligible waste production. This proposal focuses on the exploration of a
unique family of halogenating enzymes, specifically the bacterial site-specific vanadium dependent
haloperoxidases (VHPOs), that use a coordinated vanadate ion (VO43-) and co-substrate hydrogen peroxide to
oxidize aqueous halide ions and install them in a regio- and stereospecific manner on organic substrates. Despite
their involvement in constructing multiple bioactive natural product scaffolds and catalyzing chemically diverse
and useful reactions without additional cofactors or coenzymes, only a small fraction of the hundreds of site-
specific VHPO homologs have been rigorously characterized. The exploration of this poorly defined chemical
and biochemical space is what intellectually drives this proposal. Using interdisciplinary chemical, biochemical,
and genomic techniques, we aim to better understand bacterial site-specific VHPO enzymology through three
independent, yet interrelated objectives. The first involves the genomic identification and categorization of novel
VHPO homologs available within publicly available repositories. Improved representation of microbial site-
specific halogenases will permit us to correlate genomic sequences to biochemical reactivities with the ultimate
intention of predicting chemistries directly from bioinformatic signatures. The second objective involves
understanding the roles of uncharacterized VHPOs within bacterial secondary metabolism and chemical ecology.
The majority of known bacterial site-specific homologs catalyze chemically unique reactions in natural product
biosynthetic pathways; these biochemistries are critical for establishing the bioactivities of their cognate products.
We propose that novel VHPO reactivities and diverse substrate scaffolds remain to be discovered, and that the
use of homologous genes as biosynthetic ‘hooks’ will facilitate the genome-based identification of new secondary
metabolites. Finally, we aim to define the structural determinants of halide and organic substrate specificity for
synthetic applications, either within their native substrates or expanded to novel scaffolds. These objectives will
simultaneously improve our understanding of VHPO halogenation enzymology at the substrate and
macromolecular level and will facilitate biocatalytic efforts to apply these site-specific microbial halogenases
towards chemically useful transformations.

Public health relevance
Project Narrative Bacterial site-specific vanadium dependent haloperoxidases (VHPOs) are a unique family of halogenating enzymes that oxidize aqueous halide ions and install them in a regio- and stereospecific manner on organic substrates. This proposal merges interdisciplinary chemical, biochemical, and genomic techniques to identify novel VHPO homologs from diverse microbes, characterize their roles in secondary metabolism and chemical ecology, and define the structural determinants of halide and organic substrate specificity. By expanding the characterized VHPO repertoire, we will provide new biosynthetic tools for the construction of biomedically relevant small molecules and biocatalytic alternatives to conventional organic chemistry halogenation strategies.